Development of a High Throughput Screening Assay for RORgamma

DESCRIPTION (provided by applicant): The human nuclear hormone receptor (NHR) superfamily consists of 48 members approximately half of which have no identified ligands and are termed "orphan receptors". Nearly all of the NHRs with identified ligands have been successful targets for drugs treating a variety of diseases including diabetes, dyslipidemia, inflammation, and cancer. The retinoic acid receptor related orphan receptors (RORs) are members of the NHR superfamily and include three receptors (RORa [NR1F1], ROR[unreadable] [NR1F2] and RORγ [NR1F3]) that have diverse functions and patterns of expression. No functional natural ligands have been characterized for these 3 receptors and, additionally, there are no validated synthetic ligands to use as probes to characterize the biological roles of RORs currently exist. Thus, development of screening assays for identification of ROR ligands is essential to address the physiological function of these receptors. This proposal focuses on development of screening assays to identify specific RORγ ligands. RORγ is a particularly interesting NHR and putative drug target because of the role it plays in the biology of an effector-memory CD4+ T cell lineage known at the Th17 cell, which produces IL-17. Th17 cells have an important role in the pathophysiology of autoimmunity and tissue inflammation and RORγ is known to regulate the differentiation of Th17 cells as well as direct the expression of IL-17. Thus, inhibitors of RORγ function that inhibit Th17 cell proliferation may be effective for treatment of diseases involving inflammation and autoimmunity. In order to identify RORγ chemical tools that could be used to investigate the role of RORγ in these processes as well as to validate the possibility of targeting this receptor for the treatment of immune disorders, we propose the following specific aims: (1) Develop and validate a biochemical assay to detect RORγ ligands in a high-throughput screen format;(2) Develop and validate secondary assays for the purpose of characterizing "hits" identified in a RORγ high througput screen;and (3) Perform a validating screen of the RORγ assay flow scheme using the LOPAC 1280 chemical library. PUBLIC HEALTH RELEVANCE: The human nuclear hormone receptor (NHR) superfamily consists of 48 members approximately half of which have no identified ligands and are termed "orphan receptors". Nearly all of the NHRs with identified ligands have been successful targets for drugs treating a variety of diseases including diabetes, dyslipidemia, inflammation, and cancer. This proposal focuses on development of screening assays to identify specific RORγ ligands. Inhibitors of RORγ may be effective for treatment of diseases involving inflammation and autoimmunity.

Public health relevance
PROJECT NARRATIVE The human nuclear hormone receptor (NHR) superfamily consists of 48 members approximately half of which have no identified ligands and are termed "orphan receptors". Nearly all of the NHRs with identified ligands have been successful targets for drugs treating a variety of diseases including diabetes, dyslipidemia, inflammation, and cancer. This proposal focuses on development of screening assays to identify specific RORγ ligands. Inhibitors of RORγ may be effective for treatment of diseases involving inflammation and autoimmunity.